Towards a quantum-mechanical understanding of proton-coupled electron transfer and transition metal reactivity in biological processes

Project Summary/Abstract
A fundamental understanding of biological processes is necessary to further the advancement of
therapeutics and technologies that will benefit human health. In principle, the laws of quantum mechanics
hold the key to such an understanding, with the potential to reveal (with the highest resolution possible)
every detail of physiological processes that occur naturally in biological systems, and relevant mechanisms
of action that can be harnessed to combat disease and improve health. In practice, however, despite rapid
advances, state-of-the-art methodologies for investigating quantum phenomena are still rather limited, as
experimental techniques face difficulties of resolution and interpretive ambiguities while exact theoretical
predictions require computational effort which grows exponentially with system size. This proposal aims to
utilize and further develop promising computational methods, to be used in concert with experimental
techniques, to provide unprecedented insights into proton-coupled electron transfer (PCET) processes and
the catalytic ability of transition metals that occur naturally in biology. The first proposed research aim
involves the combination of two-dimensional electronic vibrational spectroscopy and excited-state electronic
structure calculations to probe the ultrafast PCET dynamics in a biomimetic, synthetic model compound of
Photosystem II. This work will yield general insights regarding the PCET motif which is ubiquitous in human
biology, and which plays a critical role in diseases such as Amyotrophic Lateral Sclerosis. The second aim
will develop an efficient computational protocol to accurately predict the binding affinity of potential drug
candidates into protein sites that contain transition metal ions. This technology will nearly double the
number of druggable targets that can be tackled with rational drug design platforms, and will accelerate the
discovery of a wide range of new therapeutics. The third research aim seeks to investigate the
multireference electronic structure of metal complexes with non-innocent ligands, in particular the motif of
heme binding to O2 as found in oxygen transport and the catalytic cycle of cytochrome P450, and to model
the redox activity of multi-metal systems containing iron and sulfur atoms. This research will be performed
with the guidance of Martin Head-Gordon as sponsor and Graham Fleming as collaborator, both Professors
of Chemistry at University of California, Berkeley (UCB). The proposed training plan will take advantage of
the diversity of expertise and stimulating environment at UCB, with synergies present across labs,
departments, and affiliated institutions. The plan for career development involves the opportunity to mentor
graduate students, and to develop teaching, public speaking, and grant-writing skills that will help me to
achieve the goal of becoming a leader of a research group, joining a community of scientists from all
backgrounds to solve pressing problems that will lead to the improvement of health.

Public health relevance
Project Narrative This proposal seeks to provide a quantum-mechanical understanding of proton-coupled electron transfer and transition metal reactivity in natural biological settings. State-of-the-art electronic structure calculations will be used to complement spectroscopic measurements to gain fundamental knowledge about how nature efficiently transports charges, which is relevant not only to photosynthesis but also to processes such as metabolism and DNA-repair. Secondly, I plan to develop robust models to predict transition metal reactivity, to rationally design drugs which bind via metal coordination and to investigate metal bonding and catalysis relevant to oxygen transport and ATP synthesis.